Testing the impact of a multi-level intervention on cancer prevention behavior among young adults in Texas

Human papillomavirus (HPV) prevention medicine is important because it protects against cancers caused by HPV infection. Nearly 79 million people are currently infected in the United States and about 14 million people become infected with HPV each year. HPV infection can cause cancers and the financial burdens of these HPV-related diseases cost more than $8 billion per year in the US. Recently approved HPV prevention medicine can prevent up to 74% of HPV-associated invasive cancers. The Centers for Disease Control and Prevention (CDC) recommends HPV prevention medicine through age 26. Among adults18–26 years, HPV series completion is unacceptably low whereas HPV infection rates are unacceptably high. There is also a lack of interventions to improve HPV prevention medicine uptake among young adults who were not protected during childhood. This study aims to fill in the important gaps by using a 2 by 3 factorial design to test the independent and combined effects of a multilevel intervention: school-based HPV prevention services (no enhanced access vs. enhanced access) at the system level and web-based narratives (no enhanced access vs. video vs. written) at the individual level.
This intervention is developed based on pilot studies and socio-ecological models that recognize the impact multi-level factors have on behaviors. The 2 by 3 factorial design results in six groups: standard CDC information about HPV prevention (control); 2) video narratives about HPV prevention; 3) written narratives about HPV prevention; 4) access to HPV prevention medicine at school combined with standard CDC information, 5) access to HPV prevention medicine at school combined with video narratives, or 6) access to HPV prevention medicine at school combined with written narratives . This design allows us to investigate the independent and combined effects of tailored narratives and access to school-based HPV prevention medicine on its uptake. College students aged 18-26 years who are not previously administered HPV prevention medicine will be randomly assigned to one of the six groups. Primary outcomes are series initiation and completion at 3- and 9-month follow-ups, respectively. This study has implications for creating a new paradigm in HPV prevention services by inspiring future new research directions that include targeting multi-level factors to improve the uptake of HPV prevention medicine. This study will make a significant positive impact on public health, as it is using evidence-based strategies tailored for young adults aged 18-26 years. If successful, the web-based intervention can be easily disseminated because it is brief and scalable. School-based HPV prevention services can be implemented on college campuses in the future to improve healthcare delivery. Success and lessons learned in this study will inform future strategies to develop tailored narrative messages for different groups.

Public health relevance
HPV infection rates are unacceptably high among young adults in the US and there is an urgent need to reduce HPV infection by providing HPV prevention services to young adults aged 18-26 years. We expect the study to identify effective components of a multi-level intervention to boost HPV prevention medicine uptake and provide important insights about uptake among young adults. The study will have significant impacts on science and practice by inspiring future prevention approaches that include multiple levels of influence and by setting a new path to provide evidence-based strategies tailored for young adults aged 18-26 years to prevent HPV related cancers.